THE NIA GENETICS OF ALZHEIMER'S DISEASE DATA STORAGE SITE

Project Summary
NIA has established the National Institute on Aging Genetics of Alzheimer's Disease Data Storage Site
(NIAGADS) as a national genetics data repository in order to facilitate access by qualified investigators to
genotypic data for the study of the genetics of late-onset Alzheimer's Disease (AD). It is the policy of the NIA
that all Genetic Data derived from NIA funded studies for the genetics of late-onset Alzheimer's disease be
deposited at NIAGADS or another NIA approved site or both whenever possible. NIAGADS is also the Data
Coordinating Center for Alzheimer's Disease Sequencing Project (ADSP), a National Institute on Aging
initiative to identify new genetic variants by sequencing genomes/exomes of more than 30,000 AD patients and
cognitively normal controls. In the third funding period, NIAGADS will continue our primary mission as the
national repository for AD genetics and genomics, support ADSP data coordination, and collaborate with NIA-
funded and other relevant ADRD research initiatives. The growing data will evolve into a long-lasting resource
and a major legacy of ADSP. NIAGADS will: (1) Curate, update, and disseminate a high-quality, lasting data
collection with 80,000 or more genomes for ADRD genetics/genomics research; (2) Support ADSP data
production and analysis activities; (3) Develop informatics infrastructure for cloud-based data analysis,
management and dissemination; (4) Expand computational tools for genetic and genomic data annotation,
report and visualization; (5) Collaborate with other research resources and initiatives, and expand the outreach
program.

Public health relevance
Project Narrative NIAGADS is an important NIA infrastructure for Alzheimer's disease (AD) research. NIAGADS ensures high quality data and resources are available to the research community for AD genetics research.